Monitor single-cell dynamics using optically computed phase microscopy in correlation with fluorescence characterization of intracellular properties

Project Summary
The objective of this study is to develop a multi-modality imaging platform that integrates complex phase
microscopy (CPM) based on optical computation and fluorescence microscopy (FM). We will use the imaging platform to
correlate the sub-cellular dynamic motion and intracellular properties to study cell adhesion which plays an important role
in many aspects of cell behavior. This study is significant for fundamental research, preclinical and clinical study, and
technology development. By simultaneously imaging cell motion and organelle properties, CPM-FM enables the
investigation of cell dynamics in correlation biomolecular characteristics. CPM-FM investigation of cell adhesion will result
in better understanding of pathophysiology of different diseases, open the door to new methods for disease treatment and
early diagnosis, lead to the development biomaterials that need specific interaction with cells, and benefit patients and
clinicians. This study will also establish the feasibility of CPM as an imaging technology that allows non-invasive, and
continuous monitoring of cell activities without contrast agents. We will achieve the objective of this study through
developing the CPM imaging platform (Aim 1), investigating high-throughput single-cell dynamic imaging using CPM
(Aim 2) and investigating the correlation between adhesive properties using CPM and cell viability using fluorescence
microscopy (Aim 3). This project will provide a unique platform for undergraduate students to conduct research.
Undergraduate research assistants will play major roles in cell imaging, image processing, and data analysis. Undergraduate
research assistants participating in this study are exposed to multi-disciplinary research that will prepare them for a career
in the fields of biomedicine.

Public health relevance
Project Narrative The objective of this study is to develop a multi-modality imaging platform that integrates complex phase microscopy (CPM) based on optical computation and fluorescence microscopy (FM). We will use the imaging platform to correlate the sub-cellular dynamic motion and intracellular properties to study cell adhesion which plays an important role in many aspects of cell behavior.